Atlantic Center for Occupational Health and Safety Training

Atlantic Center for Occupational Health and Safety Training
Overall Abstract
The Atlantic Center for Occupational Health and Safety Training has a long history of effective training, providing over 5.1
million contact hours of hazardous materials knowledge and skills, reaching over 506,000 workers since 1987. Our Center will
train workers about safety issues during hazardous waste site clean-up, issues related to generation, treatment and storage of
hazardous materials, emergency response, and disaster preparedness and response. Our Center will also provide career
development training to unemployed and underemployed individuals, creating sustainable careers in environmental health and
safety. The courses develop competency in workers to critically analyze dangerous situations, enable them to identify safe work
practices, and make workplaces safer. Key principals of adult education are incorporated into our training. Courses are
developed to include peer-learning, hands-on activities, and development critical thinking skills. The Center has a robust
evaluation plan and will continue to expand the types of data collected on the impact of training on workplace practice, as well
as how training can more effectively influence workplace safety culture. The Center adheres to the principles identified in the
NIEHS Minimum Criteria Document. Training provided by the Center is aligned with several sections of the NIEHS Strategic
Plan. The Center proposes to continue training through the HWWTP, HDPTP, and ECWTP programs.
The HWWTP provides core hazardous waste and emergency response training. The training provides critical knowledge and
skills for those requiring training under 29CFR1910.120 and other occupational safety and health standards. Our Center
proposes to expand our capacity to reach underserved groups throughout Region 2 by adding The City College at the City
University (CCNY) and The Work Environment Council of New Jersey (NJWEC). Over the next five years, the Center
proposes 26,380 workers in 1,835 courses, providing 387,640 contact hours of training in the HWWTP.
The HDPTP enhances the safety and health of current hazardous materials workers and chemical responders by delivering
training to workers and volunteers responding to disasters. The courses focus on prevention and preparedness so that disaster
response personnel are aware of safety and health hazards and mitigation techniques before they initiate a disaster response.
The Center proposes to add the Northeast New York Coalition for Occupational Safety and Health (NENYCOSH) to
provide training in the NY State Capital (Albany) Region. Over the next five years, the Center proposes to train 9,335 workers
in 560 courses resulting in 76,415 contact hours in the HDPTP.
The ECWTP provides training to unemployed and underemployed individuals. The program creates career paths in
environmental health, allowing trainees to achieve sustainable employment. The program targets minority communities with
high unemployment and high poverty rates in low-income areas in New York City and New Jersey. The Center proposes to
add Make the Road New York to the ECWTP to increase the employment opportunities for disadvantaged immigrants. Over
the next five years, the Center proposes to train 825 individuals in 50 cohorts, in 210 courses, providing 161,250 contact hours
in the ECWTP.

Public health relevance
The Atlantic Center for Occupational Safety and Health Training will provide training in hazardous materials, environmental careers, and disaster preparedness in Federal Region 2. The public health impact of training provided by the Center will prevent and reduce injuries and illness due to potential risks during hazardous waste operations, emergency and disaster response. Training provided is the vital to educating workers in safety and health issues. The Center is well-prepared to conduct the training proposed in this application. Center members have significant existing collaborations with their proposed target populations. The Center has successfully met their training projections in previous years of funding. The Center has trained over 506,000 workers, providing over 5.1 million contact hours of training with funds from the NIEHS WTP.